EVALUATION OF GANCICLOVIR IN SYMPTOMATIC CONGENITAL CMV INFECTIONS

This is an investigation into the safety, tolerance and efficacious dosage of ganciclovir for administration to infants with congenital CMV disease in Phase I and Phase II trials.